North Dakota Cooperative Agreement to Enhance Produce Safety in Preparation of Implementation of FDA's Rule: Standards for the Growing, Harvesting, Packing, & Holding of Produce for Human Consumption

North Dakota Project Summary Project Period 2021-2026
Mission
• To provide outreach and education about the FSMA Produce Safety Rule to produce growers in
the state through education and one-on-one technical assistance.
Vision:
• Support current and new produce growers in our state by providing them with information so
they can make well-informed business decisions.
Program Objectives
• Objective 1: Program Documentation
o Overall Plans: The overall goal of this objective is to take the processes that were
written in the previous CAP and organize them to provide long term success for the
program and allow those running the program to be successful.
• Objective 2: Program Administration
o Overall Plans: The NDDA is committed to providing education to staff to help them
perform their job duties well. A well-educated staff will help achieve the overall vision
for the program.
• Objective 3: Education, Outreach and Technical Assistance
o Overall Plans: To provide FREE education and outreach to produce growers in ND.
Trainings will be during months when they are not working in the fields. Every year the
NDDA hosts a local foods conference. This is a place where smaller producers (that sell
on average less than $25,000 in produce) come to learn. Having a grower training in
conjunction with that conference provides an opportunity for those micro-exempt
growers to be trained on the FSMA Produce Safety Rule.
• Objective 4: Farm Inventory
o Overall Plans: Collect and maintain produce farm inventory information that will be
provided to the FDA on an as-needed basis. Utilize that information to better
understand where outreach and education is needed across the state.

Public health relevance
North Dakota CAP Narrative The grant funds will continue to be used to assess the needs in North Dakota (ND), develop educational materials, provide outreach, verify the ND farm inventory, and develop a multi-year strategy to address the needs of ND farmers that are affected by the FSMA Produce Safety Rule.